DOSE-RELATED NEUROBEHAVIORAL EFFECTS OF CHRONIC COCAINE USE

The purpose of this project is to assess the neurobehavioral and neuropsychological performance of cocaine abusing individuals. Although cocaine use is a significant public health problem, there is a paucity of scientific data on long-term neurobehavioral effects. This study examined the dose-related association between chronic cocaine use and neurobehavioral performance. A battery of neuropsychological tests was administered to 30 abstinent chronic cocaine abusers and 21 non- drug- using control subjects matched for age, education, and intelligence. After controlling for age, education, and intellectual ability, greater use of cocaine (grams per week) was associated with larger decrements on tests measuring executive functioning, visuoperception, psychomotor speed, and manual dexterity. These results suggest that chronic cocaine use is associated with persistent decrements in cognitive function that are most pronounced in heavy users. Knowledge of specific cognitive processing deficits in chronic cocaine users would be useful for designing individually tailored drug treatment programs. - Brain/drug effects, Cocaine, Neuropsychological Tests, Treatment - Human Subjects: Interview, Questionaires, or Surveys Only